Therapy with fecal microbiota transplantation and immune checkpoint blockade for solid tumors

ABSTRACT
Immune checkpoint blockade (ICB) with blocking anti-CTLA-4 and/or anti-PD-1/PD-L1 monoclonal antibodies
(mAbs) have induced durable clinical responses in patients with solid tumors, including melanoma, non-small
cell lung cancer (NSCLC), and HPV+ cancers. However, the majority of cancer patients still fail to respond to
ICB, supporting the need to identify predictive biomarkers of response, and develop novel therapies to
overcome the mechanisms of resistance to ICB. Multiple studies have reported that a human beneficial gut
microbiome is associated with response to anti-CTLA-4 or anti-PD-1 mAbs in cancer patients. Strikingly, there
is limited concordance among species identified across different studies, which included small number of
patients and used different analytical approaches. In addition, the administration of certain gut commensals or
responder-derived fecal microbiota transplantation (FMT) promotes efficacy of anti-CTLA-4 and anti-PD1 mAbs
in melanoma-bearing mice. Reintroduction of beneficial organisms and/or fecal microbiota transplantation
(FMT) from responding mice restores sensitivity to ICB in tumor-bearing mice. Responder-derived FMT
resensitized melanoma patients to anti-PD1 mAbs in two separate studies. In a first-in-human phase II study,
we reported that R-FMT provided clinical benefit primary refractory melanoma patients, induced rapid and
durable microbiota perturbation. Bioinformatic analysis demonstrated that the FMT-induced changes of the gut
microbiome in treated patients governed the observed immunological and metabolomic changes in the
periphery and at tumor sites. Our novel preliminary findings in melanoma support that baseline beneficial and
detrimental enterotypes predict clinical outcome and immune-related adverse events (irAEs) in PD1-treated
melanoma. They also support the hypotheses that FMT exhibiting a beneficial enterotype may :1) improve
clinical outcome upon ICB, and 2) impede the occurrence of serious irAEs. Whether these findings in patients
with advanced melanoma are relevant to large cohorts of cancer patients with melanoma, NSCLC or HPV+
cancer in distinct geographic locations has not been determined yet. These important questions are addressed
in the present translational research proposal. This collaborative project in response to PAR 18-951 between
the University of Pittsburgh and the NCI will take advantage of the NIH Clinical Center's unique access to a
large cohort of patients with HPV+ cancers treated with cancer immunotherapy.

Public health relevance
Project Narrative One of the most intriguing findings in the field of cancer immunotherapy is the recent demonstration that the gut microbiome regulates immune and clinical antitumor responses to immune checkpoint blockade (ICB) in cancer patients. Here, we propose to identify whether a baseline beneficial and a detrimental gut microbiome predict clinical outcome and immune-related adverse events to ICB in cancer patients. We will also investigate whether fecal microbiota transplant convert ICB-refractory cancer patients into responders and impede the occurrence of serious adverse events.